Third Coast Center For AIDS Research

PROJECT SUMMARY
THIRD COAST CFAR: OVERALL
The broad, long-term mission of the Third Coast Center for AIDS Research (TC CFAR) is to use our
trans-disciplinary collaborations to power transformational advances across the translational spectrum
from discovery to implementation of effective interventions - and end HIV. Many local resources at
Northwestern University (UC), the University of Chicago (UC), and community partners have been, and
will continue to be, brought to bear on this mission. The allowable Funded Research Base (FRB)
increased by 47%, and projects became more trans-disciplinary, from FY14 to FY18. Nimble and
opportunistic strategic planning (by the Administrative Core, AC) and robust growth in seed funding
and mentoring programs (by the Developmental Core, DC) led to those successes, and to choosing
specific, high-priority HIV research topics as foci for a second term. Institutional support has increased.
The Overall scientific aims were also chosen based on each of the 3 scientific Cores having a user
base and expert resources with strengths on each aim. Each of these Cores has also worked to extend
their resources and expertise to researchers outside their own domains, and thereby helped build
collaborations. The following Overall aims build on our solid foundation, and will direct each scientific
Core, in concert with the AC and the DC, to synergistically advance the science needed to end HIV.
Overall Aim 1: To continue and expand collaborative research that will slow, and eventually stop, the
HIV epidemic by improving continuums of HIV prevention and care.
Overall Aim 2: To advance understanding of accelerated aging-related illnesses (non-AIDS
comorbidities) that occur despite suppression of HIV viremia.
Overall Aim 3: To speed discovery and empower development of transformative scientific innovations
that will improve HIV prevention and treatment for persons living with HIV.

Public health relevance
PROJECT NARRATIVE THIRD COAST CFAR OVERALL RESEARCH The Third Coast Center for AIDS Research has leveraged complementary strengths of Northwestern University, the University of Chicago, and partnering community organizations across Chicago to build a comprehensive infrastructure for multi-disciplinary, collaborative HIV research. As a result, research funding and interactions have grown in our first term. This unique and catalytic integration of disciplines and venues of HIV-related research expands in this renewal proposal, aiming to accelerate HIV elimination and improving health-span for persons living with HIV.